Transgenic T cell Therapy for Acute Myeloid Leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) accounts for ~80% of adult acute leukemias and ~20% of childhood leukemias.
Among patients who initially achieve a complete remission with standard induction therapy, most will ultimately
relapse and die of disease-related complications. Allogeneic hematopoietic cell transplantation (HCT) has
reduced relapse rates and can be curative for many high-risk patients. However, HCT regimens can cause
considerable morbidity and mortality, and many high-risk AML patients are not candidates for HCT, due to age,
comorbidity and/or lack of an available donor.
Adoptively transferred autologous T cells engineered to express a high affinity T cell receptor (TCR) that
recognizes the AML-associated antigen Wilms’ Tumor Antigen 1 (WT1) represents a strategy to provide a
numerically potent immune response in the absence of HCT. WT1-specific T cells in vitro and in vivo can
recognize and kill leukemia cells due to the expression of abnormally high levels of WT1, without affecting normal
cells including hematopoietic stem cells that express lower levels of WT1. In two previous clinical trials, we
targeted the HLA A+02-restricted immunoproteasome (IP)-dependent WT1126-134 epitope, with CD8 T cell clones
or CD8 ‘TCRC4’-transduced T cells, documenting direct anti-leukemic activity and prevention of post-HCT
relapse. However, we noted AML escape after loss of IP expression and IP-dependent epitope presentation,
and/or limited persistence of transferred T cells in patients with abundant AML.
To overcome these obstacles, we now propose to utilize a high-affinity ‘TCRE50’ that targets the IP-independent
WT137-46 epitope and will be inserted in a lentiviral vector encoding CD8?? chains to produce WT137-46-targeting
CD4 and CD8 T cells. Moreover, autologous CD62L-expressing naïve and central/stem memory CD8 T cells will
be engineered, as these cells are associated with longer persistence in vivo. We plan a Phase I/II trial for
patients at high risk of AML relapse who are not HCT candidates. TTCR-E50 will be infused after induction
therapy. Shortly after the last infusion of TCR E50-engineered T cells (TTCR-E50), patients will receive azacitidine,
which can increase WT1 epitope presentation. We will use high dimensional analytic methods to identify TTCR-
E50 and AML cell parameters pre- and post-infusion that correlate with clinical responses vs. AML progression.
As the efficacy of transferred T cells has been shown to in part reflect the lack of tumor-associated costimulatory
ligands, we will also use in vitro and murine models to explore the pre-clinical safety and efficacy of providing
co-stimulatory/survival signals by co-transducing ‘switch’ receptors.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) is a deadly disease, especially for patients who have aggressive disease and who cannot receive a hematopoietic stem cell transplant (HCT). In a new Phase I/II clinical trial we propose to infuse patients who are not HCT candidates with genetically engineered T cells modified to selectively attack AML cells and prevent the disease from coming back. We also propose to perform the pre-clinical laboratory work for adding positive signals to the gene-edited cells to help them better attack the leukemia in future clinical trials.